Molecular and cellular mechanisms of neuronal damage caused by anticancer therapies

Project Summary
Cancer is a terrifying diagnosis, especially in a child, yet thanks to great advances in treatment, survival rates
have increased steeply. For CNS/brain tumors and leukemias, which together account for the majority of pedi-
atric cancers, these positive clinical outcomes generally require the use of CNS radiotherapy (RT). However, RT
causes significant long-term neurocognitive sequelae impacting not only cancer survivors, but also their caregi-
ver networks and society. Since RT is a scheduled ‘injury’, pretreatment is feasible, but the unclear nature of RT-
induced cognitive injury is a major obstacle to doing so. Research addressing RT-mediated cognitive deficits has
focused on the dividing neuroprogenitor cell (NPC) pool from which a small number of postnatal, “adult-born”
neurons arises in the dentate gyrus, as the hippocampus (of which the dentate gyrus is part) is particularly RT-
sensitive. While NPC damage likely contributes to cognitive decline, we and others have shown that terminally
differentiated neurons, long thought to be radioresistant, undergo marked synaptic alterations in response to
RT. In this proposal, we present data showing that radiation compromises the neuronal plasma membrane,
alters neuronal mitochondrial dynamics, and changes the expression of genes involved in lipid metabolism and
cholesterol biosynthesis. Moreover, we demonstrate that APOE genotype associates with post-RT cognitive
outcomes in humans. These observations hearken to long-neglected studies on non-genetic loci of radiation
damage that could give us critical insights into the mechanisms of RT-mediated cognitive damage. Many
questions remain unanswered, however: How and to what extent do these mechanisms of irradiative damage,
including membrane permeabilization, contribute to cognitive decline? Does plasma membrane compromise
affect cellular Ca2+ signaling, a known cause of aging-related cognitive decline? How are these processes affected
by the delivery of lipids from astrocytes to neurons by ApoE? What are the consequences of epigenetic changes
that affect plasma membrane lipid composition? These are critical questions whose answers are required to
rationally design therapies to combat RT-induced neurocognitive sequelae. We propose to use a quantitative,
multidisciplinary approach to address these issues, including: (i) determining the consequences of RT-induced
plasma membrane compromise with regard to initial events and effects on mitochondrial and ER Ca2+ stores;
(ii) defining the role and site of action of the lipid carrier ApoE in the neuronal response to RT, while testing the
consequences of allelic variants of ApoE and the changes in surface glutamate receptors associated therewith;
and (iii) charting the nature and consequences of altered neuron lipidomes as a result of RT, including using a
bioinformatics approach to identify key pathways and potential therapeutic targets. Our novel and multidisci-
plinary approach will dissect the nature of RT-mediated cognitive dysfunction at the molecular, synaptic, cellu-
lar, and behavioral levels. The results of this translational proposal have the potential to greatly and positively
impact the health of cancer survivors and those otherwise exposed to radiation.

Public health relevance
Project narrative. As survival rates for pediatric brain cancers and leukemias have risen strikingly over the last several de- cades, the US survivor population is steadily growing. Unfortunately, the treatments that make this possible cause brain damage, and the nature of this damage is poorly understood, hampering its treatment. Our proposal tests the hypothesis that a major locus of radiotherapy-mediated neuronal damage is the plasma membrane u- sing modern techniques and tests potential therapies for these sequelae to inform new clinical interventions for improving survivorship in cancer survivors and others exposed to radiation.